The Development and Optimization of Long-Read Sequencing Applications to Cancer Genomics in a Core Setting

Project Summary/Abstract
In the last two decades, genomic sequencing technologies have made remarkable
advancements in the quality and number of human genomes sequenced. Moreover, the emergence of
long-read sequencing has unveiled a level of genome variation and diversity that is elusive through
conventional short-read methods. Cancer is a leading cause of death worldwide, with more than 14
million new cases and 8 million deaths each year. It is often characterized by substantial
heterogeneity with respect to the cancer subtype and population group. This heterogeneity manifests
at multiple levels, including genetic, epigenetic, and transcriptomic and is fundamental to the
understanding of the mechanisms driving cancer phenotypes. Nevertheless, these variations are quite
complex and difficult to recapitulate in short-read studies.
The goal of my work as the head of the Cold Spring Harbor Laboratory Sequencing
Technology and Analysis Shared Resource (STASR) is to provide superior insight and expertise in
sequencing technologies and long-read methods in particular. Over the last four years, I have actively
engaged in the development of long-read sequencing strategies and collaborated with researchers to
harness this powerful tool to meet their scientific goals. I intend to continue to develop and optimize
sequencing strategies such as single-cell full length RNA methods, ultra-long (>100kb) DNA
sequencing, novel strategies for long read target enrichment, DNA and RNA modification analysis
and, to improve general accessibility to genome sequencing technologies.
My track record of facilitating genome science at CSHL has proven me to be an essential
resource to the scientific mission of the Cold Spring Harbor Laboratory Cancer Center. My ultimate
goal is to facilitate collaborative research by directing work across various core facilities, fostering
interdisciplinary research, and innovating to address fundamental questions in biology and cancer
science.
The transformative advancements in genome sequencing technologies, including the
breakthrough of long-read sequencing, have shed light on the previously elusive depth of genome
variation and diversity. My commitment to developing and optimizing advanced sequencing strategies,
coupled with my vision of fostering collaborative research across core facilities, underscores my
determination to address fundamental questions in biology and cancer science.

Public health relevance
Project Narrative Cancer is a leading cause of death worldwide, with more than 14 million new cases and 8 million deaths each year. New advances in sequencing technology are uncovering the genomic mechanisms that drive cancer development and progression including the complex genetic, transcriptomic, and epigenetic drivers of this disease. Expertise and comfort in these new approaches are essential to a successful cancer research program to facilitate better diagnosis and treatment options.